Research Capacity Building Core

Project Summary/Abstract - Capacity Building Core
Capacity-building efforts in LMICs are critical to advancing the science of implementation and to have global
impact on cancer inequities. Implementation science capacity strengthening is still in the nascent state for chronic
diseases focused on LMICs, particularly in the context of cancer control efforts. The synergistic research and
cores proposed in the U54 Center are well-poised to address these key gaps and aligned with the priorities of
regional stakeholders. The overarching goal of the Capacity Building Core within the Empilisweni Center for
Women’s Health is to increase implementation research opportunities and capacity in cancer control in the
Western Cape Province of South Africa through didactic and experiential implementation science training and
mentorship for a range of interested researchers, clinicians, and implementation practitioners. The Capacity
Building Core builds off of and extends our team’s nearly three decades of partnership in cutting-edge clinical
research in cervical cancer screening, and existing educational and research capacity and longstanding
partnerships. Aligned with our Center’s theme on advancing equitable and integrated implementation for cancer
control in South Africa, our Specific Aims for building sustainable research capacity to conduct cancer control in
IS include: 1) Deliver a sustainable implementation science training and career development program using the
train-the-trainer model, mentorship, and innovative educational and capacity-building activities, that will enhance
local knowledge of core competencies in the field of implementation science (e.g. foundational theories,
frameworks, strategies, and methods; economic evaluation), supplemented with relevant cancer control and
career development training and opportunities. Leveraging our team’s experience in IS capacity-building and
knowledge dissemination and utilization, this program will be delivered among a range of trainees (researchers,
clinicians, practitioners, community health workers) in South Africa at UCT & MOH, and will build sustainable
implementation research capacity regionally, providing the foundation to equitably scale-up evidence-based
cervical cancer control innovations in the region. 2) In partnership with the Research Projects and Stakeholder
Engagement Core, trainees and stakeholders will help inform and co-lead the development, application,
evaluation, and refinement of implementation science frameworks (e.g. Knowledge to Action, CFIR, RE-AIM),
implementation strategies, and training tools that reflect local context and stakeholder input, with a focus on our
Center’s theme. This Core has the expertise and infrastructure to successfully support and enhance the
professional and career development of investigators and implementers in IS (including 2 lead IS Fellows), with
the ultimate goal of strengthening local capacity and building a sustainable cadre of scholars and practitioners
who are prepared to conduct and lead IS research for cancer control in this region.